The University of Miami AIDS Research Center on Mental Health and HIV/AIDS - Center for HIV & Research in Mental Health (CHARM)Research Core - Methods

PROJECT SUMMARY: METHODS CORE (C)
Building off our success as a Core in the D-ARC, in this transition to a Full ARC, we will expand upon our
services and training in statistical analysis techniques, research design, qualitative approaches, mental health
(MH) measurement, and data management. Because of CHARM’s theme related to reducing the impact of MH
and minority health disparities across the HIV prevention and care continua, we focus on multi-level methods.
MH comorbidities are inherently individual-level processes. In contrast, MH and minority health disparities are
driven by higher-level structural socio-cultural processes that exist at the various levels (e.g., neighborhoods,
cities, regions) within which individuals are nested. Therefore, interventions and approaches of Center
investigators are likely to address both individual and socio-cultural processes and, thus, be multi-level.
The Methods Core is responsible for promotion of state-of-the-science research design (statistical
methods and qualitative approaches) via consultation in multi-level research that will inform local
implementation of evidence-based practice consistent with CHARM goals. Activities to address this aim include
providing consultation to MH-HIV researchers developing grant proposals (as well as post-award support) and
supporting early-stage investigators with CHARM Developmental Core Awards Program studies in the areas of
research design, use of biomarkers of HIV and its comorbidities, and analytic strategies.
To optimize resource-sharing and collaboration on MH-HIV research among CHARM investigators, the
Methods Core will expand a unified data architecture, centralized data repository, and collaborate across cores
on an instrument library. The voluntary unified data architecture includes common data elements to facilitate
collaboration and cooperative projects to utilize CHARM data in ways not possible in single studies. The Core
also maintains databases for both consent-to-contact databases implemented by the Mental Health Disparities
and Community Engagement Core and the CHARM REDCap Measures Library of well-established validated
instruments; including Spanish and Haitian Creole-language measures of constructs relevant to HIV and MH.
Finally, the Methods Core provides triaged access to CHARM resources, state-of-the-science
methodology workshops, and other capacity-building activities focused on addressing MH disparities in HIV.
Via the CHARM Research Navigation Portal, investigators and community partners are provided coordinated
access to all CHARM resources, methodology consultations, and methods-focused workshops with content on
machine learning, reproducibility, multilevel modelling, geographically-focused analysis, intersectionality,
reliability and validity across populations, and model selection approaches. The Core also facilitates
consultations and presentations from other CHARM Cores and affiliated research groups, such as the CFAR,
CTSI, NIDA’s National Drug Abuse Treatment Clinical Trials Network, and NIDA’s P30 CHERISH Center,
which focuses on cost-effectiveness analysis.

Public health relevance
PROJECT NARRITIVE As a D-ARC, the Center for HIV and Research in Mental Health (CHARM) successfully re-ignited and dramatically grew high-impact meaningfully community-engaged research efforts and infrastructure at the University of Miami, located in a region of the U.S. that is one of the hardest hit geographic areas affected by the HIV/AIDS epidemic. Transitioning to a Full-ARC after successfully meeting D-ARC goals will capitalize on our trajectory, facilitating continued growth of multidisciplinary research addressing HIV-related mental health disparities and the impact of these disparities on the HIV care and prevention continua.